Investigating the Role of Alternative Splicing Regulatory Networks in Nervous Sys

Research Summary: Investigating the Role of Alternative Splicing Regulatory Networks in Nervous System Development and Function Alternative pre-mRNA splicing, a process generating multiple distinct mRNA transcripts from a single precursor transcript, has played a critical role in the evolution of transcriptome complexity and cellular diversification in metazoans. It is therefore not surprising that alternative splicing events are frequently subject to regulatory control in a cell- and tissue-type dependent manner. However, despite significant advances made in our understanding of the mechanisms governing tissue-specific alternative splicing regulation, there is still much to learn. For instance, only a small number of splicing factors with tissue-specific expression patterns have been identified, and collectively these factors cannot account for the degree of alternative splicing regulatory complexity observed in diverse cell-types. Even less is known about the extent and control of differential regulation of splice variants between individual cells of a tissue-type or organ, owing in part to limitations in the detection of these isoforms. Finally, only a few studies have begun to address the functional roles of tissue-specific splicing regulators and the networks of splicing events they control in cellular differentiation and specialization. Here, we propose to use the Caenorhabditis elegans nervous system as a model to advance our understanding of alternative splicing regulation in vivo. First, we will employ genome- wide approaches to elucidate the regulatory network controlled by the neuron-specific CELF family splicing protein UNC-75, a factor known to be required for proper neuronal function. We will then perform a detailed investigation of this network using genetic techniques and isoform-specific analyses to identify genes and splice variants that are the most significant downstream effectors of UNC-75 in modulating neuronal function. Finally, we propose to conduct genetic screens to identify novel regulators of neuronal cell-subtype specific alternative splicing patterns. The identification of these cell-subtype specific regulators will open the door to additional investigation of alternative splicing networks in specific classes of neurons. Taken together, the aims described in this proposal will reveal new insights into how regulation of alternative splicing at the level of individual cells can be achieved, and how the study of alternative splicing regulatory networks can be used to infer previously unknown functions of genes and isoforms in key developmental processes.

Public health relevance
Project Narrative: Investigating the Role of Alternative Splicing Regulatory Networks in Nervous System Development and Function The goal of this proposal is to determine how cells of the nervous system can interpret their genetic material to produce the building blocks necessary for key functions such as the transmission of electrical signals and interpretation of environmental cues. State-of-the-art approaches will be used to make fundamental discoveries about how these basic processes influence the health and diverse abilities of organs such as the brain. __SpecificAimsTextDelimiter__ Specific Aims: Investigating the Role of Alternative Splicing Regulatory Networks in Nervous System Development and Function The major goal of this proposal is to gain a deeper understanding of the mechanisms and consequences of alternative splicing regulation that contribute to complex functional and behavioral phenotypes in the nervous system. Particular focus will be placed on identifying and characterizing known and novel regulators of cell- type specific alternative splicing and the network of splice variants they regulate. To address these questions, Caenorhabditis elegans has been chosen as an ideal model system because of the ease and scale that genetic analyses can be performed in this organism, in addition to its simple but well differentiated nervous system and invariant cell lineage to facilitate the identification of cell-specific splicing events. Many of the principles discovered from the experiments described in this proposal will translate to more complex eukaryotes such as mammals, providing general conceptual advances in our understanding of the role of alternative splicing regulators and their associated regulatory networks in neurobiology. The anticipated goals of each aim are described in greater detail below. Aim 1: Identifying the AS regulatory network regulated by UNC-75, a CELF RNA binding protein We hypothesize that UNC-75, a member of the CELF family of splicing regulators and critical regulator of neuronal function and locomotion, modulates these phenotypes through its control of alternative splicing of a network of target transcripts. Two next-generation sequencing-based approaches will be utilized for the elucidation of the network of splice variants regulated by UNC-75. First, large-scale analysis of transcriptome dynamics by next-generation sequencing (RNA-Seq) will be used to compare alternative splicing patterns between wild-type and unc-75 mutant animals. Second, next-generation sequencing coupled with cross-linking and immunoprecipitation experiments (CLIP-Seq) will be performed to identify the transcripts that UNC-75 physically associates with. Collectively, these approaches will assist in the identification of the most comprehensive neural AS regulatory network to date for a member of the CELF family of splicing factors, and will provide an important set of target transcripts and corresponding genes that UNC-75 regulates to achieve proper control of neuronal function. Aim 2: Splicing network-driven discovery of genes and isoforms regulating neuronal function The potential requirement of candidate genes with UNC-75 regulated alternative splicing events in neuronal function will be tested using RNAi and genetic loss-of-function studies. Additionally, these same approaches will be applied to study synthetic genetic interactions and identify potential functional relationships between genes within the network. Finally, two new resources that I have developed will be used to investigate the roles of specific splice variants regulated by UNC-75 in neurons. First, a fluorescent reporter system that can monitor alternative splicing events in vivo and at single cell resolution will allow observation of splicing patterns of these candidate isoforms in neurons during animal development. Second, a splice variant-specific transgene expression technique will allow the direct assessment of isoform functions at the synapse in vivo. Collectively, these powerful approaches will uncover isoforms, genes, and molecular pathways not previously known to be involved in regulating neuronal function. Aim 3: Identification and characterization of novel regulators of neuronal subtype-specific splicing In this part of the proposal, the fluorescent reporter system described above will be applied in RNAi and unbiased forward genetic screens to identify novel regulators of neuron subtype-specific alternative splicing events. A subset of these factors and their regulatory networks will then be characterized using existing approaches and the techniques described above in aims 1 and 2. Together, our methods will uncover a new set of factors, some of which may belong to classes of regulators not previously known to play a role in splicing, that control these types of alternative splicing events. Furthermore, the characterization of the networks regulated by these factors will identify novel genes and splice variants that may be required for the specific functions of diverse neuronal subtypes.